The network structure of childhood adversities and adult depressive symptoms in rural Uganda

PROJECT SUMMARY
Adverse childhood experiences (ACEs), including abuse, household dysfunction, and neglect, are pervasive in
resource-limited settings and exert consequences on mental and behavioral health across the lifespan.
Preliminary data from rural Uganda, the site of the proposed research, are consistent with this literature,
demonstrating robust associations between ACEs and adult depression symptom severity, major depressive
disorder, and suicidality. Yet researchers have raised concerns about the accuracy with which ACEs are
retrospectively reported. The theory of mood congruent memory biases suggests that individual factors at the
time of assessment (e.g., affective states) may influence reporting. A second limitation of this literature is that
the cumulative disadvantage operationalization of ACEs obscures our understanding of the pathways linking
ACEs and depression. Without this information, the field lacks the empirical scaffolding needed for the design
of targeted intervention programs that can effectively address the mechanisms through which ACEs influence
depression. The fellowship candidate of this proposed F31 award seeks to achieve the long-term goal of
becoming an independent investigator with expertise in identifying risk and protective factors for mental health
and in developing novel peer-delivered and social network interventions that harness positive social and
cultural dynamics to increase access to evidence-based mental health care in low resource settings. Three
training objectives are proposed: (1) psychometric and longitudinal data analysis, (2) advanced social network
analysis, and (3) psychological symptom network analysis. This training will be consolidated through
secondary analyses of sociocentric social network data from the co-sponsor’s population-based cohort study in
a rural region of southwestern Uganda (N=1,772). Three specific aims, tightly linked to the training objectives,
are proposed: (1) determine the test-retest reliability of retrospectively-reported ACEs and estimate correlates
of changes in reporting over time; (2) estimate the co-symptomatology network of depression symptoms and
ACEs; and (3) assess the extent to which individual social network characteristics are associated with the
structure of the co-symptomatology network. The key innovation of this F31 application is that it proposes the
first study to integrate a psychological symptom network analysis with rich sociocentric social network data.
The fellowship candidate will receive individualized mentorship by a team of sponsors and consultants with
complementary expertise—paired with focused coursework, workshops, meetings, and readings—thereby
ensuring acquisition of the statistical skills needed to accomplish these aims. The findings are expected to
have significant public health impact by informing the design of accessible, resource-efficient interventions that
target central ACEs and depression symptoms.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is aimed at determining the reliability of retrospectively-reported adverse childhood experiences (ACEs) and estimating the network structure of ACEs and symptoms of depression. As such, the proposed research is specifically relevant to NIMH Goal 2 of examining mental illness trajectories across the lifespan and clarifying the complex relationships between social determinants and risk and resilience to mental health, in order to advance our understanding of mental health disparities. The proposed research is also relevant to the NIMH cross-cutting theme of global mental health research.